Controlling Interareal Gamma Coherence by Optogenetics, Pharmacology and Behavior

PROJECT SUMMARY/ABSTRACT Coherence between cortical regions has been implicated in cognitive functions including attention and working memory. Coherence may act to dynamically alter the routing of information through the brain, providing the flexibility that is necessary for cognition. Indeed, disruptions in coherence are linked to neural disorders such as schizophrenia and autism spectrum disorder. There has been no systematic, in vivo, study of how inter-cortical coherence arises. Here we will test the hypothesis that inter-area cortical gamma (30-80 Hz) coherence occurs when local oscillations in a source region propagate to, and synchronize with, a target region. Computational modeling predicts that the strength of pre-existing gamma in the target will affect its coherence with an incoming oscillation: 'weak' local gamma oscillations will be easily entrained, leading to coherence between the two regions, while 'strong' oscillations resist external input, making coherence difficult (unless the input matches in phase and frequency). Testing this hypothesis requires causal in vivo control of local oscillations, a technique that the Moore laboratory has recently developed utilizing optogenetics. Coupling optogenetics with multi-area recording will allow us to discover the rules of how oscillations cohere between areas. We will optogenetically induce local gamma oscillations in a source area (primary somatosensory cortex, SI) and measure their coherence with a target area (secondary somatosensory cortex, SII). We will test our hypothesis by manipulating the strength of ongoing gamma oscillations in the target in three ways. In Aim 1, we will optogenetically induce gamma oscillations in the target, parametrically varying the power and phase, in order to determine their effect on coherence. Cholinergic agonists induce gamma oscillations in the neocortex and acetylcholine may underlie the inter-areal coherence observed in attention. Therefore, in Aim 2, we will induce gamma oscillations in the target by increasing the local cholinergic tone and measuring its impact on coherence. Rodent, monkey and human data link gamma oscillations with attention. So, in Aim 3, we will test the impact of attention on the ability to optogenetically induce local gamma, and its impact on establishing coherence between areas. These aims will directly test an important hypothesis about the mechanism of inter-areal coherence. In addition, this proposal will allow me to learn optogenetic, electrophysiological, and behavioral techniques in mice, under the mentorship of Dr. Christopher Moore. My future career goals are to combine my previous primate experience with these new techniques in mice. I will use electrophysiology in primates trained to perform complex behaviors to generate hypotheses about the neural mechanisms underlying cognition. These proposed neural mechanisms can then be dissected using the powerful methods available in mice.

Public health relevance
Project Narrative This project will investigate how brain regions achieve coherence with one another in the gamma oscillation band. Coherence is thought to aid in the communication between brain regions, and alterations in gamma expression and in inter-areal coherence are found in several mental and brain disorders, including schizophrenia and autism. Our work may, therefore, provide insight into these maladaptive changes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS There is increasing evidence that synchrony between brain regions is important to cognitive functions. In particular, oscillations in the gamma band (30-80 Hz) have been found to be important to attention and working memory. For example, my previous work in non-human primates demonstrated that inter-areal gamma coherence between frontal and parietal cortex, two critical regions for cognitive control, varied with whether attention was internally motivated or externally captured. Experimental evidence such as this, coupled with theoretical work, has led to the hypothesis that coherence between regions can dynamically alter the routing of information through the brain. This mechanism may provide the flexibility that is fundamental to cognition. Indeed, disruptions in synchrony are linked to several neural disorders, including schizophrenia and autism. Despite its theorized importance in cognition, the fundamental mechanism of how two brain regions become coherent is unknown. Definitively addressing this requires causal in vivo control of locally generated oscillations. Dr. Christopher Moore's laboratory, where I will continue my training, has developed optogenetic techniques to do exactly this (e.g., Cardin et al., 2009; Cardin et al., in press Nature Protocols). Coupling optogenetics with multi-area recording will allow me to discover the rules of how oscillations cohere between areas. Here, I will test the hypothesis that gamma coherence between a source and target area is influenced by the intensity of pre-existing gamma oscillations in the target region. Computational modeling by my co-mentor, Dr. Nancy Kopell, predicts that local gamma power defines how an area will cohere to an arriving, non-local oscillation. 'Weak' local gamma in the target facilitates entrainment to an incoming gamma, thus boosting inter- areal coherence. In contrast, 'strong' local gamma in the target resists synchronization. This differential response could provide the cognitive flexibility desired: Incoming gamma oscillations, and the information they carry, are either captured by the target or they are rejected. We will test this hypothesis using three different approaches to inducing gamma oscillations and coherence: Aim 1. I will test the hypothesis that the intensity of optogenetically induced gamma oscillations in a target region determines its coherence with an incoming gamma oscillation. I will test our hypothesis by inducing local oscillations in a source region (primary somatosensory cortex, SI) while parametrically varying the power and phase of local oscillations in the target region (secondary somatosensory cortex, SII). Aim 2. I will test the hypothesis that the intensity of cholinergically-induced gamma oscillations in a target region determines its coherence with an incoming gamma oscillation. Cholinergic agonists induce gamma oscillations in the neocortex and are likely the top-down neuromodulatory mechanism that facilitates the inter-areal coherence observed in attention. I will test how varying cholinergic tone alters gamma oscillations in the target (SII) and impacts its coherence to incoming gamma which will be induced in SI using optogenetics. I will induce gamma oscillations in the target by increasing cholinergic tone in three ways: direct application of muscarinic or nicotinic agonists, stimulation of the reticular formation, and optical stimulation of local acetylcholine release from innervating axons using ChAT transgenic mice. Aim 3. I will test the hypothesis that attention alters the efficacy of local optogenetic gamma induction and that the intensity of attention-induced gamma in the target determines its coherence with an incoming gamma oscillation. Rodent, monkey and human data find attention increases gamma both within and between areas. I will train mice to attend into/out-of the somatosensory modality, allowing me to test the effect of attention on optogenetically inducing local gamma and establishing inter-areal coherence. We will also causally test the attention-by-synchrony hypothesis by determining the behavioral impact of optogenetically increasing local gamma oscillations and their inter-areal coherence. These aims not only test important hypotheses, but extend my training in an important direction. My previous work has studied complex behaviors in primates. Specifically, I am interested in how the interactions between brain regions underlie cognition and I have developed large-scale electrophysiological techniques to address this in monkeys. This has led to hypotheses of how oscillations and synchrony underlie cognitive computations. Continuing my training with Dr. Moore will broaden my experimental skill set and allow me to begin to parse the neural mechanisms of coherence. This proposal reflects the balance I intend to have in my career. Electrophysiology in primates performing complex behaviors will generate new hypotheses about the neural mechanisms underlying cognition. The powerful methods available in mice will allow me to dissect these proposed neural mechanisms. This synergy between animal models, and the spectrum of techniques available, will provide the foundation for a laboratory generating novel insight into the neural basis of cognition.